Investigating Cellular Immunometabolic Mechanisms Underlying HIV-Related Cardiovascular Disease Risk

Older people living with HIV (PLWH) disparately experience an increased risk of cardiovascular
disease (CVD) and develop exacerbated age-related cardiometabolic comorbidities compared to
uninfected individuals. Multiple risk factors in older people living with HIV including
aging, HIV alone, antiretroviral therapy, microbial translocation, traditional CVD risk
factors, lifestyle, opportunistic infections, and substance abuse create the "perfect storm" for
increased immune activation, systemic inflammation, atherosclerosis, and CVD. Indeed,
studies suggest the features driving an elevated risk of CVD include both HIV-specific, and
traditional and non- traditional CVD risk factors. Yet, therapeutically targetable biological
mechanisms driving an exacerbated HIV- related CVD burden remain unclear. Our previous work
identified immunometabolism dysfunction as a mechanism linked to age-related comorbidities in
PLWH. Targetable immunometabolic features and immune cell types differentially dysregulated in
older PLWH linked to increased CVD risk remain undefined. With a multidisciplinary team
including expertise in immunometabolism, cardiology, radiology, and infectious disease, we are
uniquely positioned to uncover immunometabolic changes as a key mechanism linking HIV-mediated
immune activation and inflammation to CVD comorbidity burden. We will leverage an established
cohort of older PLWH at WCM and enroll 100 HIV+ participants (age > 50 years) all on suppressive
ART with undetectable plasma HIV RNA in a longitudinal study with three study visits to assess
inter- and intraindividual variability in immunometabolic study measures. We will apply a
state-of-the-art single cell immunometabolism assay of fresh immune cells obtained from
participants in real-time at three time points to overcome artifacts of
cryopreservation, profile validated inflammation and cardiac injury biomarkers, and
acquire longitudinal advanced cardiovascular and vascular bed CT imaging at baseline and a 36
month follow up time point. Our central hypothesis is that the synergistic effects of HIV and long
term ART on CVD comorbidity burden is driven by an exacerbated metabolic reprogramming of monocytes
and T cells towards glycolysis in older PLWH on ART. The specific aims are Aim 1: To longitudinally
assess the immunometabolic state of monocytes and T cells at single cell resolution, peripheral
inflammation, and cardiac injury markers in 100 PLWH > 50 years on stable ART. Aim 2: To quantify
the change over time in the degree of subclinical plaque burden across the vasculature in 100
PLWH > 50 years on stable ART and evaluate associations with immunometabolic states of
monocyte and T cell subpopulations. The results of this longitudinal study will enhance our
understanding of inter- and intraindividual immunometabolism dysfunction in older PLWH linked to
subclinical atherosclerosis, provide a roadmap for early detection of CVD based on the individual
level and type of risk, and lead to the development of new therapeutics based on exploiting the
specific metabolic programs of distinct immune cell populations to mitigate CVD risk in older PLWH.

Public health relevance
PROJECT NARRATIVE This proposal will study elderly people living with human immunodeficiency virus (HIV) longitudinally over 3 years for cardiovascular health. Cardiometabolic diseases disproportionately develop in people living with HIV, and we are looking for new treatments to mitigate cardiometabolic disease and tools to predict the development of adverse cardiovascular health outcomes in blood samples. We will study participants’ blood cells immunometabolic changes longitudinally, proteins that make energy, and acquire longitudinal cardiovascular and whole body vascular imaging to advance our understanding of cardiovascular health in the HIV field.